HMGB1, Chlorpyrifos, and Persistent GWI-like Neuropathology

Approximately 25-30% of U.S. veterans who served in the 1990–1991 Gulf War are affected by Gulf War
Illness (GWI). GWI is a devastating and debilitating condition, where GWI symptoms present as both central
nervous system (CNS) and peripheral symptoms, including widespread pain, musculoskeletal pain, headache,
persistent cognitive deficits, fatigue, stomach and intestinal symptoms, respiratory complaints, and skin
abnormalities. Recent studies support abnormal hippocampal pathology in GWI veterans with cognitive
deficits, highlighting an important CNS link. One critical and prominent feature of GWI is that symptoms persist
and in some cases progress, long after the Gulf War, now over 25 years later. Epidemiology supports that
pesticide exposures, such as chlorpyrifos (CPF), may be linked to cognitive effects of GWI, but the underlying
mechanisms are unknown. The neuroinflammation hypothesis of GWI cognitive deficits holds that CNS
immune perturbation may drive the persistent CNS effects in GWI. Microglia, the resident myeloid (immune
origin) cells in the brain, have been implicated as a chronic source of pro-inflammatory factors driving
progressive neuron damage in diverse CNS conditions, including GWI. Recent reports indicate that peripheral
injury augments the brain's pro-inflammatory response to cause neuronal pathology through circulating factors.
Our over-arching hypothesis is that peripheral and CNS injury interact in GWI and in response to the GWI-
relevant pesticide, CPF, where circulating damage associated molecular patterns regulate the chronic
microglial pro-inflammatory response and consequent neuronal/memory deficits. Preliminary data indicate the
chronic CPF GWI mouse model causes persistent neuroinflammation, chronic hippocampal synaptophysin
loss, and neurobehavioral deficits 3 months after the last pesticide injection, validating the GWI model. Data
also point to a role for HMGB1 in CPF effects, as the CPF GWI mouse model exhibited elevated circulating
HMGB1 in bioactive serum, HMGB1 injected by tail vein elicited neuroinflammation/microglial activation, and
HMGB1 directly triggered microglial activation in vitro. Mechanistically, microglia depletion was confirmed as
neuroprotective against CPF in vitro. Thus, our specific hypothesis is that CPF exposure causes bioactive
circulating factors (HMGB1), which then cause persistent microglial activation/neuroinflammation and GWI-like
neuropathology. As such, the following AIMS will: 1) Define the neuroprotective efficacy of HMGB1 inhibition in
a CPF model of delayed and persistent GWI-like neuropathology; 2) Confirm the role of myeloid cells in GWI-
like neuropathology; 3) AIM3: Examine the neuroimmune bioactivity of GWI-like serum. These findings will
provide much needed insight into the role of the periphery in the persistent response to GWI-relevant
pesticides (CPF), implicate HMGB1 and temporary myeloid cell depletion as novel therapeutic targets, and
begin to outline a neuroimmune bioactivity assay as a potential marker for GWI.

Public health relevance
These findings will reveal key mechanisms defining how circulating signals in the blood and microglia/myeloid cells interact to result in persistent neuroinflammation, neuropathology, and cognitive deficits in response Gulf War Illness-like exposures (i.e. chlorpyrifos), creating critical opportunities to intervene in the chronic effects of Gulf War Illness and pesticide exposures, mitigating pathology to improve health.